High-resolution ex vivo microCT for biomedical imaging

Project Summary
The goal of this application is to replace an essential, 14 year old in-vivo microCT imaging system at the
Seattle Children’s Research Institute (SCRI) with a state-of-the-art Bruker Skyscan 1272 high-resolution 3D ex-
vivo microCT imaging system. This instrument is required to conduct a diversity of research projects, which
require imaging both at large-scale (whole organisms/organs) and microscopic-scale. This imaging resource
will support the activities of 11 major and 4 minor users focused on three cross-cutting research themes: (1)
Genetic mutations underlying human congenital syndromes that affect multiple organs, (2) development and
pathology of vasculature, (3) mechanisms of tissue regeneration after ischemic damage or injury, and (4) basic
research in bone biology and remodeling. A portfolio of 18 funded and 4 pending NIH grants, as well as
funding from other federal agencies like NSF currently supports these projects. This exciting new technology
allow users to rake benefits from the technological improvements introduced to microCT imaging and sample
preparation in the last decade. As shown in our pilot data, with the new ex-vivo system we will be able to image
tissues with higher resolution, with better image quality and clarity compared to our current end-of-life
instrument. Further, some of the listed projects involve tedious phenotypic screens, which have been
hampered by the manual sample navigation and data acquisition with our existing system. With an automated
sample changer and a control software that automatically determines the optimal settings, based specimen
dimensions, the proposed equipment will help our users overcome these problems, and achieve higher
analytical throughput, while obtaining better quality data. There is strong Institutional commitment for the
instrument, including state-of-the-art imaging space, coverage of service contracts, maintenance personnel
effort in at least the first 5 years, backed-up data storage, and 3-D image analysis resources. While SCRI and
University of Washington investigators comprise the main user group, these instruments would be accessible
to other investigators from allied institutions such as the Fred Hutchinson Cancer Research Center, Institutes
for Systems Biology and others, creating a unique and valuable community resource for macroscopic-to-
microscopic imaging. In addition, there is extensive imaging expertise present at the SCRI Center that will
house and support the device (PI, Maga, Co-I, Shih and Yu). This will guide the proper use, time allocation and
maintenance of the instrument. This imaging resource would immediately influence the productivity and
innovation of ongoing work and will be critical in furthering the long-range objectives of the biomedical
community in the greater Seattle area.

Public health relevance
Project Narrative This application is to provide biomedical researchers at the Seattle Children’s Research Institute, University of Washington, and the greater Seattle area with a Bruker Skyscan 1272 microCT imaging system. This state-of- the-art instrument will enable the study of diverse biological specimens across a range of spatial scales, spanning whole organisms/organs to microscopic structures. This unique imaging resource is essential to the productivity of numerous NIH-funded projects.